CWRU NEI Vision Center Core Grant

ABSTRACT
Overall Component
The Visual Sciences Research Center (VSRC) at Case Western Reserve University (CWRU) requests
continuing support for a P30 Core Grant for Vision Research. The VSRC was founded in 1996 and has
undergone tremendous growth since the first P30 grant award in 1997 and subsequent grant renewals in 2002,
2007, 2011, and 2016. The CWRU P30 Core Grant has enhanced and expanded individual investigators’
programs, facilitated inter-investigator and inter-departmental collaborations, and helped bring new
investigators within CWRU to the visual sciences, both junior and established. Our VSRC is now comprised of
36 PIs in 13 clinical and basic science departments from the two CWRU Schools and the CWRU College of
Arts and Sciences. These investigators conduct innovative, impactful, and interdisciplinary research on
fundamental mechanisms in the retina, causes and treatment of common retinal diseases as well as study
normal and pathologic processes in the anterior segment of the eye. Our current NEI grant portfolio is diverse
and encompasses many funding mechanisms. These include 14 eligible NEI R01s, 1 NEI UG1, 3 NEI R21s, 1
NEI T32, and 2 NEI F30 grants. In addition, our VSRC investigators hold 20 grants from other NIH Institutes.
The VSRC is strongly supported by the CWRU School of Medicine, University Hospitals Cleveland Case
Medical Center, and the CWRU Department of Ophthalmology and Visual Sciences, which provide significant
funds for bringing new PIs to vision research, repair and purchase equipment, service contracts, a partial
salary support of the core managers as well as on the seminar series and annual VSRC symposiums. We
request support for the 3 resource Cores: 1) Specialized Animal Resources; 2) Molecular Biology and
Genotyping; and 3) Analytical Services. All three Cores are expected to be heavily utilized and lead to
successful accomplishment of the three unifying grant’s Specific Aims: 1) to enhance the capabilities and
productivity of the eligible NEI R01 holders as well as other VSRC investigators by providing them with
services, resources and facilities that are too costly for an individual laboratory; 2) to increase scientific
interactions among the VSRC investigators by sharing resources and expertise; 3) to bring new investigators to
vision research, both junior and established.

Public health relevance
NARRATIVE Overall Component This P30 Core Grant provides essential infrastructure and expertise for the investigators of the Visual Sciences Research Center at Case Western Reserve University who study major inherited and acquired blinding diseases such age-related macular degeneration, diabetic retinopathy, retinitis pigmentosa, Leber’s congenital amaurosis, Stargardt’s disease, Fuchs dystrophy, and glaucoma. Through its critical functions, this grant will continue to enhance the ability of vision researchers to decipher the mechanisms of many common blinding diseases and develop new therapies for their treatments. The grant will also facilitate collaborations among vision researchers and will help bring new investigators to vision field.